Regulation of embryonic patterning and adult stem cells of oral appendages

DESCRIPTION (provided by applicant): Understanding the molecular and cellular mechanisms regulating the development, patterning and postnatal renewal of oral ectodermal appendages such as teeth, taste papillae and filiform papillae, and identifying stem and progenitor cell populations in these organs, is critical for developing regenerative strategies to replace missing teeth in cases of congenital absence or loss through disease; for understanding and treating disorders of taste, including those resulting from radiation therapy and small molecule anti-cancer drugs; and for delineating proliferation controls that may be dysregulated in oral cancers. The Wnt/ -catenin signaling pathway is necessary for many developmental processes and plays critical roles in the proliferation and self- renewal of adult stem cell populations. Genetic studies in mice reveal key functions for Wnt/ -catenin signaling at early stages of tooth and taste papilla morphogenesis. Signaling is activated broadly prior to the initiation of tooth and taste papilla development and gradually becomes restricted to sites of tooth and taste precursor development, ensuring correct positioning of tooth and taste organs. Based on our preliminary data, we hypothesize that proper localization of Wnt signaling requires competing activities of Wnt ligands and secreted Wnt inhibitors, and that these direct organ formation by spatially controlling the fates, movements and proliferation of oral epithelial cells. We will use live imaging of embryonic oral explants from mice that express chromatin-localized GFP specifically in Wnt-activated cells or in all basal epithelial cells, together with ubiquitous expression of membrane Tomato, to ask whether genetic deletion of Wnt inhibitors, or loss of a Wnt ligand important for tooth development, cause altered cell movements and/or patterns of proliferation. Filiform and taste papillae of the tongue are continuously renewed in adult life, an a subset of human patients with mutations in WNT10A presents with adolescent onset of oral ectodermal defects including smooth tongues. We hypothesize that WNT10A/ -catenin signaling controls proliferation and/or survival of adult stem and progenitor cells required for renewal of taste and filiform papillae. To test this we will ask whether loss of Wnt10a in mice affects -catenin signaling and the proliferation, survival, or differentiation of tongue papilla progenitor cells and will fate map Wnt responsive cells in the adult tongue to test whether they include self- renewing progenitors. To determine whether Wnt signaling is necessary for survival of functional progenitors, we will test whether inhibition of filiform and taste papilla proliferaton upon inducible transgenic expression of the Wnt inhibitor DKK1 is reversible after removal of the inducing agent. These experiments will delineate mechanisms controlling proliferation and organ renewal in the oral cavity and will provide important information for designing regenerative strategies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding the mechanisms that control proper positioning of teeth during embryonic development and renewal of taste papillae and other tongue epithelia in the adult oral cavity is critical for developing regenerative strategies to replace missing teeth in cases of congenital absence or loss through disease; for understanding and treating disorders of taste, including those resulting from radiation therapy and small molecule anti-cancer drugs; and for delineating proliferation controls that may be dysregulated in oral cancers. The goals of this proposal are to understand the mechanisms that control proper positioning of teeth and taste organs; and to identify stem cells involved in renewal of taste and tongue epithelia in adults and delineate how they are regulated. Results from these experiments will suggest potential strategies for regenerating oral organs and treating taste disorders and oral cancers.